Mayo Comprehensive Cancer Center Grant

OVERALL PROJECT SUMMARY
The Mayo Clinic Cancer Center (MCCC) is a comprehensive cancer center that has been a designated NCI
Center in Rochester, MN (MCR) since 1974. Today, MCCC includes not only MCR, but also sites in
Jacksonville, Florida (MCF), and Scottsdale/Phoenix, Arizona (MCA). Each site has a thriving clinical cancer
practice with clinical investigators at each of the sites, and a critical mass of basic science and population
sciences faculty as well. In 2013, NCI recognized MCCC as an integrated comprehensive cancer based at all
3 sites, based on shared leadership, shared research including multi-investigator grant activity, co-author
publications, and enterprise-wide clinical protocol activity. Robert B. Diasio, MD, has been director of MCCC
since 2006, leading the center through successful competitive renewals of the CCSG application in 2008 and
later in 2013. Since 2013, the center has continued to flourish with strong cancer-focused research, many
examples of team science (e.g., SPOREs), an increase in high impact publications and many examples of
translational research, and, most importantly, many examples of practice-changing approaches to cancer care.
Following strategic planning in 2014, MCCC now has the following aims:
1. To advance the cancer-focused research of each of our MCCC members within our existing 10 Programs
and within potential future Programs in order to promote high impact science.
2. To advance interactions of our MCCC members within Programs (intraprogrammatic); across Programs
(interprogrammatic); and with individuals at other Cancer Centers and institutions (interinstitutional).
3. To advance new approaches for the treatment of cancer by facilitating translation of basic science concepts
from the laboratory to the clinic within MCCC.
4. To continue to build and to further integrate cancer research activities at MCA, MCF, and MCR and to
extend these activities to the Mayo Clinic Health System (MCHS).
5. To further develop cancer education for patients, high school, college, and graduate students,
postgraduates, as well as faculty.
6. To extend our cancer research, practice, and education within our catchment areas at each of our 3 major
sites in MCA, MCF, and MCR and the MCHS with the ultimate goal of lessening cancer burden.
We will use these 6 specific aims to further the mission of MCCC: (1) to promote and facilitate research on the
incidence, etiology, and molecular basis of cancer, and (2) through education and direct application of the
results of such research, to translate the discoveries into improved methods for cancer prevention, detection,
diagnosis, prognosis, and therapy.

Public health relevance
PROJECT NARRATIVE This Cancer Center Support Grant provides the infrastructure support to facilitate basic, clinical, and population sciences research relevant to cancer research conducted at the Mayo Clinic Cancer Center. The Center's ultimate goal is to lessen the cancer burden on patients.